Core A: Administrative Core

PROJECT SUMMARY – ADMINISTRATIVE CORE (CORE A) The Administrative Core (Core A) serves the administrative and oversight needs of each Project and Core, with the specific responsibility of ensuring each aspect of the HN SPORE is progressing to its individual translational, clinical or career enhancement goal. Due to the centrality of this Core and its associated administrative function, the organ specific database (OSD), a large, longitudinal, prospectively collected, easily searchable, clinical database is now housed in Core A. It is directly supported by the HN SPORE with over 12,000 individual patients and clinical records. The Core A directors will oversee data requests from the OSD as well as the integration of additional ‘-omics’ and imaging functionality that is ongoing and will be completed over the course of the proposed HN SPORE period. The Core A directors will also oversee the work of the Core A Clinical Research Coordinator who, along with institutional support, coordinates the clinical trials of the HN SPORE. The Core A Co-Directors will also facilitate interactions between full projects, Developmental Research Projects, Career Enhancement Program Awardees, and Cores, identifying new opportunities and potential changes in direction of each study performed within the HN SPORE. Collectively, the Core A leadership team monitor expenditures, coordinate monthly HN SPORE meetings, invited speakers, at least bi- annual Executive Committee meetings, Internal and External Advisory Board meetings and Inter-SPORE meetings. Core A is also the primary point of contact for all NCI, inter-and extra-institutional communications and coordinates multi-institutional clinical trials. Additionally, Core A coordinates research and lay publications, website development, HNSCC advocacy activities, fund-raising, and additional outreach efforts. Core A is critical to the coordination of the HN SPORE, specifically working to ensure the successful completion of the HN SPORE aims as well as more generally fostering a continued culture of highly impactful translational research at HCC, with a goal of changing practice in the management of HNSCC.

Public health relevance
PROJECT NARRATIVE – ADMINISTRATIVE CORE (CORE A) The Administrative Core (Core A) is critical in coordinating the efforts of the HCC HN SPORE by providing oversight on all aspects HN SPORE activities as well as housing and improving the HN SPORE organ specific database (OSD), which includes data collected from over 12,000 patients with head and neck cancer.